Leveraging Mammalian Cancers, Platinum-Quality Genome Assemblies, and Large-Scale Data to Identify Mechanisms of Rare Human Cancers

PROJECT SUMMARY
Studying cancer across a diverse array of species provides a unique opportunity to interrogate factors
underpinning cancer initiation and progression and facilitating the modeling of new therapeutic targets in the
setting of spontaneous tumors complicated by comorbidities and metastases. While there is extensive reporting
of the frequency and diversity of tumors in animals from zoos, it has not been systematically linked to the plethora
of genomic resources available. To facilitate the transition of comparative oncology studies from human plus one
or two other species, to pan-mammalian analyses, we propose building a pan-mammalian tumor compendium
and portal to easily disseminate our resource. We will develop and apply machine learning tools to detect
patterns of cancer emergence and cancer resistance in human and non-human mammalian tumors. Our
approach provides opportunities to leverage the largely understudied mammalian tumor data jointly with human
data to identify reciprocal links between evolution and cancer resistance. This will allow us to make new human
cancer discoveries through integrative analysis of high-throughput biological data in the context of mammalian
species. We offer a powerful approach combining high-quality reference genomes and genomic data from
hundreds of mammalian species with machine learning, that has the promise to unearth the evolutionary genetic
underpinnings that are cornerstones of cancer initiation and progression. We will develop and apply models to
identify mammalian tumors that effectively mimic rare human cancers, work with collaborators to acquire tumor
samples from strongest identified mammalian models, then sequence and analyze these samples to validate
their effectiveness as models of human cancers.

Public health relevance
PROJECT NARRATIVE The emerging field of comparative oncology may provide a novel solution to rare human cancer studies, as genomic resources, reference genomes and non-human model cancer sequencing data are proliferating rapidly. We propose to, for the first time, develop and apply new machine learning methods to jointly analyze and integrate information from hundreds of mammalian genomes to identify pan-mammalian mechanisms of cancer resistance and susceptibility, and apply those insights in human cancers. To disseminate this date to the wider community and catalyze further research we will develop a tumor compendium, portal, and toolkit that will allow other researchers to leverage pan-mammalian comparative genomics.